Epigenetic gene regulation in the germline

One of the greatest mysteries in biology concerns how life has perpetuated, and continues to
perpetuate, from generation to generation. A key feature of the mammalian germline is
its sexual dimorphism: spermatogenesis and oogenesis. These dimorphic developmental
processes are inherently complex, and this complexity poses significant challenges to
understanding the perpetuity of life and the development of treatments for various germline-derived
genetic and epigenetic diseases. Thus, in this R35 application, our research directions converge
to address the following question: How do epigenetic mechanisms govern distinct sexually
dimorphic processes in spermatogenesis and oogenesis, culminating in the generation of functional
sperm and eggs? Since I became independent ten years ago, I and my team have worked to construct
a detailed picture of the epigenetic mechanisms that govern mammalian spermatogenesis. We
have shown that the mitosis-to-meiosis transition in germ cell development is notable for not only
global changes in gene expression but the dynamic reorganization of the epigenome; in brief, we
have revealed that meiosis itself is a process of global epigenomic reprogramming. My research
program has pioneered these concepts and developed innovative approaches to decode germline
mechanisms crucial for preparing the next generation, providing a rigorous foundation for future
research.
To understand key sexually dimorphic processes, we focus on fundamental
processes in spermatogenesis and oogenesis. In spermatogenesis, postnatal germ cells enter a stem
cell stage, undergo meiosis, and sustain long-term production of sperm. We will elucidate the
global epigenetic mechanisms underlying spermatogenesis from the stem cell stage to sperm
production, with an emphasis on dynamic changes in the epigenetic machinery and their
importance to the next generation. Since, in males, meiotic sex chromosome inactivation (MSCI)
functions as a key sexually dimorphic process, we will also determine the molecular functions of
DNA damage response pathways-which direct MSCl-in the epigenetic regulation of the sex chromosomes.
In contrast, female germ cells undergo meiosis in embryos and enter a prolonged stage of
meiotic arrest-spanning decades in humans-prior to oocyte maturation. We will determine
epigenetic mechanisms underlying critical stages of oogenesis to complement our study of
male germ cells. Ultimately, we will reveal distinct features and unifying principles of
spermatogenesis and oogenesis. Taking all of this together, we are uniquely positioned to clarify
how fundamental germline mechanisms intersect to ensure genome maintenance, genome defense, and
epigenetic gene regulation on a systemic level. The research directions proposed in this
application are cohesive and synergistic, with high potential to sustain research
progress and inform significant, transformative advances in germline biology, human
reproduction, and reproductive health in general.

Public health relevance
The proposed research is relevant to public health because defects in germline mechanisms are responsible for various genetic and epigenetic diseases. This study has high potential to identify novel epigenetic mechanisms that govern distinct sexually dimorphic processes in spermatogenesis and oogenesis. The outcome of this study will contribute to significant, transformative advances in germline biology, and to our understanding of human reproduction and reproductive health.